Investigating in vivo neuronal endolysosomal dynamics in health and aging using C. elegans

Project summary
Converging evidence suggests that dysfunction of the lysosomal system, responsible for degrading cellular
waste, is a critical factor underlying neurodegenerative disease and neuronal aging. However, how this age-
related impairment manifests in neurons is not well-understood. This proposal will leverage the power of in
vivo subcellular imaging of neurons in the nematode Caenorhabditis elegans to investigate the dynamic
behavior of neuronal endolysosomal organelles and their aging-related decline. In Aim 1, the applicant Zoe
Cook will train with mentor Dr. Kang Shen to characterize in vivo neuronal endolysosomal dynamics across C.
elegans aging, using the highly branched PVD sensory neuron as a model. Ms. Cook will ﬁrst methodically
characterize the ﬂow of endolysosomal and autophagic degradative traﬃcking in a healthy neuron using
multiple compartment marker proteins, a pH sensor, and an in vivo protein degradation assay. She will then
utilize these tools to deﬁne aging-related dysfunction in aged worms and mutants with altered lifespans. In
Aim 2, Ms. Cook will investigate the mechanism and function of endolysosomal dynamics in neurons,
speciﬁcally tubulation, or the extension of elongated membrane tubules. In her preliminary work, the applicant
has identiﬁed the transmembrane lysosomal protein PIPP-4P, homologous to human TMEM55B, as a
negative regulator of age-dependent endolysosomal tubulation in neurons. While TMEM55B is a known
mediator of lysosomal transport and stress response, this function has not been previously reported;
furthermore, TMEM55B has not been investigated in neurons. Ms. Cook will leverage approaches developed
in Aim 1 to determine the mechanism by which PIPP-4P regulates endolysosomal tubulation and then
manipulate tubule dynamics in vivo to establish their functional relevance in neurons. The training plan is
tailored to enable candidate Zoe Cook to develop subject area expertise in endolysosomal biology in the
context of neurodegenerative disease, as well as practical skills for data analysis, scientiﬁc presentation, and
team leadership. The collaborative and innovative Neurosciences Interdepartmental Program at Stanford
University will be an outstanding environment for Ms. Cook to build a strong background in neuroscience
research and learn from world-renowned scientists to reach her research and training goals. Mentor Dr. Kang
Shen is a leading expert in neuronal cell biology. Dr. Shen's expertise in C. elegans neuroscience will be
complemented by consultants Dr. Monther Abu-Remaileh, Dr. Marius Wernig, and Dr. Tom Clandinin, all
experts in diverse approaches to investigating lysosomal biology in the context of neurodegenerative disease.
The proposed research will generate insights into how the endolysosomal system is dynamically regulated in
neurons and where aging-related dysfunction develops, potentially informing future therapeutic approaches.
Furthermore, the strong mentoring team, institutional environment, and training plan will fully prepare Zoe
Cook for a postdoctoral position, the next step in her journey towards becoming an independent investigator.

Public health relevance
Narrative Neurodegenerative disease is a prevalent and growing cause of death and disability worldwide, with major unknowns about the underlying cellular mechanisms halting the development of new treatments and diagnostics. Both normal aging and many forms of neurodegenerative disease have been linked to dysfunction in lysosomes, the cell's recycling system, but we lack a comprehensive understanding of how lysosomes are adapted to the unique needs of the neuron. This proposal will investigate the dynamic behavior of lysosomes in neurons within an intact, living organism, expanding our body of knowledge about fundamental cell biology underlying aging and neurodegenerative disease.